Laboratory

Principal Investigator/Program Director (Last, First, Middle): Young, William L. Abstract The Laboratory Core (Core C) will provide infrastructure and experimental methodology for the program. Core C will function as a small animal surgical lab, a cellular and molecular biology lab, an imaging analysis lab, and a transgenic animal breeding unit.